COMPUTER ANALYSIS OF GEL ELECTROPHORESIS

The goal of this project is to allow NIH scientists to easily and accurately quantitate one- and two-dimensional gels. New software has been developed to utilize the features of the image processing facility and to more easily and quickly analyze gels, autoradiographs, and data from hybridization experiments.